Immersive Escape Room Gamification: Transportation Hazmat Incident (iERG)

Abstract
The transportation industry faces significant risk to health, safety and property during the shipping, handling,
storage, and disposal of hazardous materials (hazmat). The United States transports approximately one million
shipments of hazardous materials daily, accounting for about 12% of the country's total freight tonnage (U.S.
Department of Transportation, 2022). If not handled properly, exposure to hazardous materials can cause
harm to the human health and the environment, resulting in respiratory issues, skin irritation, and even death.
Strict protocols, adequate training, and proper safety gear are essential for minimizing risk when working with
and around hazardous materials. Traditional training methods often fail to engage workers or adequately
prepare them for real-world scenarios. Additionally, Hispanic workers are disproportionately impacted from
occupational exposure to chemicals resulting in injuries and fatalities. To address this critical need to improve
workplace safety with innovative methods, we propose the development of: Interactive Escape Room
Gamification: Transportation Incident (iERG), an awareness level training program utilizing an immersive
educational escape room formatted in both English and Spanish, bridging the language barrier and ensuring
that more workers have access to vital safety information and training.
iERG is a virtual escape room, scenario-based experience in which learners are challenged to locate clues,
solve puzzles, and accomplish tasks while racing against the clock to safely escape a hazmat situation. This
unique approach combines the thrill of an escape room with rigorous hazmat training, creating an engaging
and effective learning environment. This simulated escape room transforms a complex hazmat situation into a
game-based learning training program. Game-based learning improves the quality of the educational process
through motivational interaction (Cordova & Lepper, 1996) with educational escape rooms in particular
showing positive learner outcomes, perceptions, and engagement Eukel & Morrell, 2021). iERG will be
designed to simulate a realistic awareness-level hazmat situation, requiring users to apply their knowledge and
skills to solve puzzles, make decisions, and successfully "escape" the hazmat scenario. The interactive nature of
the escape room enhances retention and understanding of hazmat protocols, while also fostering teamwork and
communication skills among participants. The prototype will include a detailed scenario of a hazmat incident
in both English and Spanish, tailored to the specific needs of transportation and warehouse workers. We will
collaborate with the Freight Division of the International Brotherhood of Teamsters (IBT), transportation
experts and safety professionals to ensure the training is both accurate and thoughtfully designed to meet
educational objectives and enhance the overall safety and preparedness of transportation workers when faced
with a hazmat situation.

Public health relevance
Project Narrative Interactive Escape Room Gamification: Transportation Hazmat (iERG) is an innovative online training program creating an immersive transportation-related training program in an escape room format, combining engaging scenarios and rigorous educational challenges to improve safety practices for awareness-level transportation workers that may face a hazardous material incident. The Phase I prototype scenario contains a realistic hazmat situation with the arrival of a shipment at a warehouse facility, related puzzles, activities, clues, and tailored educational content that challenges the user’s knowledge and problem-solving abilities to safely escape the incident while racing against the countdown timer. This immersive and engaging learning experience provided in English and Spanish is designed to enhance knowledge retention, encourage teamwork and communication skills, and reinforce important safety protocols and emergency procedures.